BLOOD DRAWING FOR COMPONENT PREPARATION

The purpose of the blood drawing for component preparation is to obtain cells, proteins, DNA or lipids from healthy volunteers and dyslipidemic subjects for use in research.